KIR and MHC Class I Immunogenetics in SIV Infection

Natural killer cells provide a critical early defense against viral pathogens by virtue of their ability to
recognize and kill virus-infected cells without prior antigenic stimulation. This is accomplished through the
integration of signals from killer-cell immunoglobulin-like receptors (KIRs) and C-type lectin receptors
(NKG2A and NKG2C) on NK cells and their MHC class I ligands on target cells. KIR and HLA class I
polymorphisms can have profound effect on the course of HIV-1 infection and the efficacy of NK cell-based
therapies for eliminating virus-infected cells. However, animal studies to address the underlying
immunological mechanisms have been hampered by our limited understanding of NK cell receptor
interactions in nonhuman primate models. For MERIT extension of R37 AI095098 “KIR and MHC class I
immunogenetics in SIV infection”, we will build on recent success defining the MHC class I ligands of
rhesus macaque KIRs, isolating antibodies to these receptors, and investigating the effects of viral peptides
on KIR-MHC class I interactions. We will also extend these studies to assess the influence of viral peptides
bound by MHC-E on interactions with macaque NKG2A and NKG2C and to test the hypothesis that
adaptive NKG2C+ NK cells have a significant impact on the course of SIV infection. Aim 1 will determine
how KIR polymorphisms shape ligand recognition and generate reagents (antibodies and MHC class I
tetramers) for differentiating these receptors on primary NK cells. Aim 2 will investigate the influence of
viral peptides bound by MHC class I ligands on KIR and NKG2A/C interactions to address alternative
hypotheses concerning the role of peptides in enabling NK cells to differentiate virus-infected cells from
healthy cells or to facilitate immune evasion. Aim 3 will assess the contribution of adaptive NKG2C+ NK
cells to the outcome of SIV infection by depleting these cells during the acute and chronic phases of SIV
infection. This animal study will also afford an opportunity to investigate longitudinal changes in the
phenotypic properties of NKG2A+ and NKG2C+ NK cell subsets in response to SIV infection using KIR-
specific reagents generated in Aim 1.
RELEVANCE (See instructions):
The proposed studies will provide an essential foundation for investigating natural killer (NK) cell responses
to simian immunodeficiency virus (SIV) in rhesus macaques as a nonhuman primate model for HIV/AIDS
and will explore fundamental mechanisms by which NK cells differentiate virus-infected cells from healthy
cells and contribute to the control of immunodeficiency infection.

Public health relevance
RELEVANCE (See instructions): The proposed studies will provide an essential foundation for investigating natural killer (NK) cell responses to simian immunodeficiency virus (SIV) in rhesus macaques as a nonhuman primate model for HIV/AIDS and will explore fundamental mechanisms by which NK cells differentiate virus-infected cells from healthy cells and contribute to the control of immunodeficiency infection.